Tufts IRACDA

The Tufts IRACDA Program will serve the national need for university and college faculty trained in bio-medical
research and optimally prepared for the multiple challenges faced by professors in their first independent
position. To be successful, these individuals must set up and manage a productive research lab, obtain grant
funding, and develop and deliver innovative science courses. They must understand the value of diversity in
the scientific workforce and be able to inspire the next generations of scientists through the teaching and
research opportunities they offer. Tufts IRACDA will address these challenges by providing exceptional
postdoctoral scholars with the research portfolio and career skills needed to succeed in an academic research
environment that includes mentoring of future biomedical researchers. To achieve our goals, we will partner
with three local institutions: the University of Massachusetts, Boston, Pine Manor College and Bunker Hill
Community College, all of which are committed to educating students from groups underrepresented in the
biomedical research workforce. Our Tufts IRACDA program builds upon our successful TEACRS postdoctoral
training program. With TEACRS, we developed valuable teaching and research collaborations with our partner
faculty and students. Tufts IRACDA will utilize new initiatives to enhance the research and scholarship of our
postdoctoral scholars and build upon our existing strengths in teaching and career development. These
initiatives will broadly prepare our scholars for academic positions at the nation's top universities and colleges
and increase the impact of Tufts connections at our partner schools. To do this, we will:
• Recruit and prepare the nation's best postdoctoral scholars for successful careers in tenure-track,
academic positions in the biomedical sciences by providing strong research training.
• Prepare our scholars to create and deliver impactful science curricula to diverse student populations.
• Foster research and mentoring partnerships that encourage undergraduates at our partner institutions
to engage in independent research and pursue biomedical science careers.
Tufts provides outstanding opportunities for research training in the traditional biomedical disciplines as well as
areas such as biomedical engineering, nutrition, and behavioral sciences. Scholars will spend on average 75%
of their time conducting research and 25% of their time in career development and teaching activities, including
teaching. Similar training, along with comprehensive career mentoring, enabled us through TEACRS to place
88% (36/41) of our alumni in academic faculty positions well-suited to their career goals, a percentage
markedly above the national IRACDA average of 73%. In the new Tufts IRACDA program, we will strengthen
the training in research and research-related career skills such as grant and manuscript writing, so that we
place scholars in a more balanced mix of research-intensive and primarily undergraduate institutions. We plan
to support a total of nine scholars each year from IRACDA funds and three from institutional support.

Public health relevance
The Tufts IRACDA program specifically addresses the need for outstanding biomedical scientists who will excel as researchers, teachers, and mentors in an academic setting and the need to enhance the diversity of the biomedical workforce. Tufts IRACDA will provide postdoctoral scholars with rigorous hands-on training in biomedical research so that they acquire the tools needed to establish independent research programs, and also prepare them to handle the challenges of teaching and mentoring. By partnering with three local undergraduate institutions committed to serving under-represented minority (URM) students, our scholars will be trained early in their careers to teach and mentor a diverse student body, thus inspiring URM undergraduates to pursue research careers and enhance the diversity of the next generation of scientists.